Administrative and Research Support Core

Project Summary
The Administrative and Research Support Core (Core A) provides the infrastructure that allows CDHA faculty
affiliates, pre-doctoral students, post-graduate fellows and academic staff to carry out research and training on
health and aging. Core A ensures the smooth functioning of other CDHA cores, maintains a stable and effective
system for the governance and administration of the center, ensures an efficient administration of center
resources, and offers exceptional support for the preparation and submission of grant applications as well as the
management of internal and external awards. It also supports staff who coordinate research events and training
activities and promote the dissemination of research findings and relevant information about sources of
extramural funding. Core A’s research and grant administration services ultimately serve to enhance the
productivity of researchers within the Center. The Administrative Core supports the overall mission of the Center,
advancing the scientific understanding of population aging and health, by freeing CDHA affiliates to focus their
efforts on their research and by supporting development, training, and dissemination activities.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is in the Overall section of this proposal.